Molecular mechanisms of target-specific synapse formation

PROJECT SUMMARY/ABSTRACT
Proper brain function requires that neurons make specific types of synapses with specific types of target neurons.
Defects in this process of synapse specficity can alter brain activity and may underlie many types of mental
illnesses but we know little about the mechanisms by which synapse specificity develops. We recently discovered
that the cell adhesion molecule Kirrel3 is selectively required to form a specific type of synapse that connects
DG neurons to GABA neurons in the hippocampus. This synapse provides feed-forward inhibition to CA3 and
Kirrel3 null mice have significantly elevated CA3 neuron activity. This established Kirrel3 as a functionally
relevant target-specific synaptogenic molecule but we still do not know the mechanism of Kirrel3 function.
Through a series of in vitro assays, our new preliminary data suggests that Kirrel3 binds other Kirrel3 molecules
in cis and trans, directs the assembly of pre- and post-synapses, and its function requires yet to be identified
neuronal molecules. Here, we will test the central hypothesis that homophilic, trans-cellular Kirrel3 interactions
nucleate DG-to-GABA synapses in vivo by recruiting synaptic proteins to axon-dendrite contact points. In Aim 1,
we will determine precisely where, when, and how much Kirrel3 is required to build hippocampal DG-to-GABA
synapses in vivo. In Aim 2, we will identify Kirrel3 signaling mechanisms by defining properties controlling the
differential subcellular localization of Kirrel3 isoforms and identifing Kirrel3 interacting proteins. Together, the
study of Kirrel3 provides a new approach to identify the still elusive mechanisms of target-specific synapse
formation and a framework for understanding how changes in synapse specificity impact hippocampal circuit
function, which plays a central role in learning and memory processes.

Public health relevance
Public Health Relevance Statement Kirrel3 is necessary to form specific types of neural connections called synapses and genetic changes in Kirrel3 are emerging as a risk factor for autism, intellectual disability and, other mental illnesses. Therefore, our research to determine precisely how Kirrel3 regulates synapse form and function is expected to contribute to understanding the fundamental cellular defects underlying brain diseases and, possibly, new ways to treat them.